Vascular Contributions to Cognitive Impairment and Dementia (VCID)

PROJECT SUMMARY
Recent research advances support the significant role of vascular factors in neurodegeneration, cognitive
decline, and dementia, including Alzheimer's disease (AD) and AD-related dementias (ADRDs). These vascular
contributions encompass issues that include small vessel disease, cerebral amyloid angiopathy (CAA), and
blood-brain barrier dysfunction. Conventionally, dementia resulting from vascular problems was labeled as
vascular dementia, while AD was linked to neurodegeneration due to amyloid plaques and neurofibrillary tangles.
However, recent data indicate that these conditions form a spectrum which includes mixed etiology dementias,
where multiple brain pathologies coexist. Efforts to elucidate and understand the causal changes that underlie
the vascular contributions to cognitive decline and dementia are being advanced by the use of genetic and
biomarker studies in humans and model organisms, aided by implementation of new multi-omic technologies.
However, despite the growing importance and relevance of this area of biomedical research, there is currently a
lack of specialized conferences that address this topic and that provide a forum for sharing of advances and
challenges – in particular one focused on training the next generation of scientists. To address this gap, we
propose an intensive, trainee-focused, 4-day conference in 2025 at The Jackson Laboratory (JAX) in Bar Harbor,
ME. This conference, entitled "Vascular Contributions to Cognitive Impairment and Dementia (VCID)", will
leverage participation by a variety of NIH-funded consortia to bring together nearly 100 scientists, spanning
career stages, from the fields of vascular biology, neurodegeneration, ADRD genetics, and computational
biology, as well as provide a virtual attendance option for those that cannot or choose not to attend in person.
This interdisciplinary event aims to foster data and model dissemination, networking, training, career
development, and collaboration through seminars, workshops, discussions, and group activities. These
objectives are facilitated by the residential nature of the JAX Highseas Conference Center. To achieve these
objectives, we propose the following Specific Aims: Aim 1. Organize an interdisciplinary conference and
interactive workshops on VCID. Aim 2. Promote interactions to foster collaborative research and career
advancement. Aim 3. Foster the recruitment and development of diverse junior investigators in the VCID
research field.

Public health relevance
PROJECT NARRATIVE The field of vascular contributions to cognitive impairment and dementia (VCID) has surged in interest in recent years with the acceptance that vascular dysfunction may be central to cognitive aging and in many cases of Alzheimer’s disease (AD) and related dementias. However, there is a current need for a workshop to facilitate networking and collaboration within the interdisciplinary VCID field, to provide participants access to the latest advances in this area, and to provide opportunities to focus resources to rapidly translate scientific discoveries into prevention, treatment, and cure. Thus, the purpose of the proposed Jackson Laboratory (JAX) VCID workshop is to provide a setting for participants to learn about the history of VCID, the current state of our understanding, the recent advances and the areas emerging as key for future studies, and to develop the next, increasingly diverse, generation of basic and clinical neuroscientists.